Career Development and Training

Two-year developmental grants of up to $100,000 direct costs per year (from a recurring annual pool of $600,000 for total costs) will be awarded for proposals of high promise from either new investigators beginning their research careers or more established investigators who are entering a new research area. Two to three new development grants will be funded each year. Applications will be solicited from individuals at Pacific-Southwest Center's member institutions, as well as at other institutions in Region IX. The applications will be reviewed first by a subcommittee of the director, associate director for career development & training, associate director for basic research, associate director for clinical research, and associate director for technology and product development with supplementation by outside reviews. Candidate proposals will then be presented to the executive committee for final selection. For years 3 through 5 a similar selection and funding process will occur for 2-year career development grants of up to $250,000 total costs per year.